Fluoride in Tooth Dentin and Neurodevelopmental Outcome in a Canadian Cohort

Project Summary / Abstract
Water fluoridation is controversial. Over the past decade, concern about the potential toxicity of
fluoride has grown, but there are still questions. Most human studies of fluoride toxicity only studied
children who were exposed to high levels of fluoride and only a few studies measured fluoride exposure
during critical periods of development. Urine, which is commonly used to quantify a person’s exposure
to fluoride, reflects recent exposure and requires serial sampling to measure fluoride during different
periods of development. Our proposed study will analyze tooth dentin – the tissue that lies beneath
enamel – to measure the level and timing of fluoride exposure. Tooth dentin is an optimal biomarker
because it provides a historical record of both serial and cumulative exposure to ingested fluoride.
We will test the following specific aims: Aim 1. To quantify prenatal, early childhood, and cumulative
fluoride exposure levels using shed baby teeth collected from 360 children; Aim 2. To examine the
association between prenatal and postnatal fluoride levels in baby teeth (dentin) and neurodevelop-
mental outcomes in infants and children (n=300 with tooth and behavioral data).
This study is innovative because it will employ state-of the-art analytical methods to measure the level
and precise timing of exposures to fluoride and toxic metals in tooth dentin. The study capitalizes on an
existing Canadian pregnancy and birth cohort, the Maternal-Infant Research on Environmental
Chemicals. We will leverage existing data from our ongoing NIH-funded study to find out if fluoride
exposure during early brain development alters children’s IQ scores and behavioral problems. Our
measurement of fluoride exposure in tooth dentin and serial urine samples offers an unprecedented
opportunity to test for neurotoxic effects of early-life exposure to fluoride.
Major contributions include: 1) quantification of exposure to fluoride during fetal development and
early childhood using tooth dentin; and 2) results that will directly impact decision making concerning
the safety of fluoride exposure during fetal development and early childhood at levels relevant to the
U.S. and Canada. Given our archived specimens collected during pregnancy, we will be able to
accomplish this study efficiently and cost-effectively.

Public health relevance
Project Narrative Controversy about the safety of water fluoridation led the National Academy of Sciences to recommend additional research on fluoride toxicity. Using an existing Canadian pregnancy and birth cohort (Maternal-Infant Research on Environmental Chemicals), this administrative supplement will be used to measure fluoride in a novel biomarker (dentin) and test the safety of chronic fluoride exposure among potentially vulnerable populations. The use of the dentin matrix will allow us to rigorously measure chronic fluoride exposure levels at levels relevant to the U.S. and Canada and to identify the possibility of discrete periods of susceptibility.